Continuation of Cooperative Agreement between U.S. Food and Drug Administration and S.C. Department of Health and Environmental Control (DHEC) for RRT Maintenance.

Project Summary/Abstract - SCRRT Maintenance Track
FOA Number: RFA-FD-23-019; Application ID: 1417421
Research and Related Other Project Information Form, Field #7
If this cooperative agreement is awarded, the South Carolina Department of Health and
Environmental Control (DHEC) and the South Carolina Department of Agriculture
(SCDA) will work in collaboration to maintain the South Carolina Rapid Response Team
(SCRRT). Alongside the Food and Drug Administration (FDA), South Carolina Meat-
Poultry Inspection Department, and South Carolina Emergency Management Division,
the SCRRT responds to human and animal food (HAF) incidents. Fulfilling the
overarching, broad objectives of this Funding Opportunity Announcement (FOA) is
essential for the realization of DHEC’s visions: utilizing standardized approaches for
food industry regulation, protecting public health, and securing the safety of South
Carolina’s food supply. SCRRT Coordinators will use relevant concepts from the RRT
Best Practices Manual to continue to build RRT capacity and framework for developing
response capability. Monthly in-person meetings between the DHEC and SCDA RRT
Coordinators and quarterly meetings with key agency personnel ensure that
collaboration and communication between the agencies occurs throughout the year, as
opposed to only in response to HAF incidents and outbreaks. Annually, SCRRT will
conduct at least one annual exercise to assess the capability of the RRT partners in
response to a HAF incident using Incident Command System (ICS) principles, including
timely notification to the FDA and other state partners and implementation of effective
control measures. An after-action report (AAR) will be used to identify policies and
procedures that require improvement. Key personnel from each agency will enhance
their knowledge and skills by completing FDA ORAU courses, developing proficiency in
environmental sampling and traceback procedures, and attending relevant meetings
and workshops. During the maintenance phase, funding for key personnel will be
transitioned from full-grant to partial-grant through supplementation of state funds
and/or alternate funding source(s); this funding transition promotes sustainability of the
SCRRT for DHEC and SCDA.

Public health relevance
Project Narrative - SCRRT Maintenance Track FOA Number: RFA-FD-23-019; Application ID: 1417421 Research and Related Other Project Information Form, Field #8 By the end of our current five-year cooperative agreement, the South Carolina Department of Health and Environmental Control (DHEC), with assistance from the South Carolina Department of Agriculture (SCDA), will have fully developed the South Carolina Rapid Response Team (SCRRT) based on national standardized objectives. If awarded this cooperative agreement, DHEC will improve our methods for protecting public health by collaborating with SCDA to successfully maintain the SCRRT and improve our processes over the three-year period. The SCRRT, a multi-disciplinary, multi-agency team composed of DHEC, SCDA, and other key state agencies, will work collaboratively to respond to all human and animal food (HAF) incidents and outbreaks to secure the safety of South Carolina’s food supply.